Dynamic GABA and Glutamate Neurotransmission in Alzheimer’s Disease and Aging

PROJECT SUMMARY / ABSTRACT
Alzheimer’s disease (AD) progression and normal aging are complex and often heterogeneous processes
involving functional changes to neuronal and glial elements that are not just related to neuronal cell loss [1-4,
143]. Prior in vitro and in vivo data support that aberrant regulation of glutamate neuronal systems can be a
contributor to neuronal degeneration in aging and likely a contributor to the age-dependent development of AD
[1, 4, 6-8]. We think that because there is a dearth of treatment and monitoring options our study will help in the
future development of therapeutics and non-invasive spectroscopic monitoring techniques for AD. Recently, we
have successfully adapted our enzyme-based microelectrode arrays (MEAs), which are designed to precisely
measure tonic and phasic neurotransmitter release in discrete brain structures in awake animals, for use in aged
rodents and AD mouse models [54-56, 79, 112]. A major knowledge gap in AD and aging involves changes in
the excitatory/inhibitory balance between glutamate (Glu) and GABA release and regulation [9-15]. We believe
that the use of our new recording technology will improve our understanding of the glutamate/GABA interplay in
an AD model and in normal aging. Our recent studies using this superior technology now allows the
measurements of tonic and phasic glutamate levels found that rats >18 months of age have normal or elevated
basal Glu levels compared to younger rats. Thus, some animals have elevated glutamate while others do not.
As outlined in NIH Notice NOT-AG-18-051 & related announcement PAR-19-070, issues surrounding age and
its role in dementia are critical in furthering our understanding of the metabolic and pathological changes that
affect signaling in neuronal circuits and networks. We will use young and aged normal and the APPNLh/NLh x
PS1P264L/P264L knock-in mouse (APP/PS1 KI) that does not overexpress APP or PS1, or use artificial promoters,
making it an ideal system for the study of how aging affects the development of AD-related neuropathology [86-
90]. We will use our novel methods to simultaneously record GABA and glutamate signaling in either the CA1
region of the hippocampus or Frontal Cortex. We will first behaviorally characterize all animals so that we can
determine potential correlations between the behavioral performance of mice and glutamate and GABA release
and/or regulation in the hippocampus (Morris water maze test) and frontal cortex (spatial memory variant of
Morris water maze test) [115] and performed as per [116]. Finally, mice that are studied will undergo a
pathological examination to evaluate neurodegeneration by evaluating reactive gliosis may be present by looking
at Iba1 and GFAP. Collectively, these studies will allow us to compare the effects of normal aging in male and
female to the effects seen from a mouse model of AD on the balance of glutamate and GABA signaling and its
relationship(s) to cognitive function in both male and female animals towards the development of novel
therapeutics to possibly treat the development and progression of AD.

Public health relevance
PROJECTIVE NARRATIVE Recent data support that changes in the functional properties of glutamate and GABA neurotransmission in the hippocampus and frontal cortex in the CNS contribute to Alzheimer’s disease (AD) and age-related declines in cognition and memory. A further understanding of the balance between glutamate levels and glutamate and GABA neurotransmission in vivo are needed from the frontal cortex and hippocampus in AD models and in normal aging. These studies will aid in the identification of targets and consistent, comparable non-invasive spectroscopic monitoring techniques for existing FDA approved drugs as well as possibly new targets for drugs to treat AD to address the growing population with dementia.